The Role of CCL5 in Hematopoietic Stem Cell Activation and Skewing

Abstract
In many inflammatory conditions such as inflammatory bowel disease (IBD) platelet counts rise, resulting in
thrombocytosis, but what initiates this platelet up-regulation is not well understood. Thrombocytosis in IBD is a
significant health concern, as it plays an active role in exacerbating disease morbidity. Increased platelet count
and reactivity in patients with IBD correlate with disease severity, and platelets actively contribute to the
mucosal inflammation and tissue-destructive inflammatory processes that are a hallmark of the disease. In
addition, due to their elevated platelet counts, patients with IBD have an increased risk of venous thrombosis.
As such, understanding the mechanisms driving this thrombocytosis and figuring out strategies to reverse it are
important knowledge gaps to address. We have recently discovered a novel regulator of megakaryocyte (MK)
differentiation and maturation known to be upregulated during inflammation, the inflammatory chemokine
ligand 5 (CCL5, RANTES). Our preliminary data revealed that CCL5 administration to healthy mice leads to
proliferation of hematopoietic stem cells (HSCs) and significantly increased platelet counts in the absence of
increasing MK progenitors. These data suggest that CCL5 may act to increase platelet counts by mobilizing
MK-biased HSCs. Consistent with this hypothesis, treatment of HSCs and MKs with CCL5 in vitro resulted in
ehanced mitochondrial and cell cycle activity, respectively. Therefore, we hypothesize that CCL5 may induce
thrombocytosis through activation of MK-biased HSCs, ultimately resulting in enhanced MK and platelet
production. Furthermore, our previously published work established a role for CCL5 in driving platelet count in
a murine IBD model. As such, our overall hypothesis is that CCL5 plays a role in inflammatory-mediated
thrombocytosis in IBD. This proposal will elucidate the mechanism by which CCL5 affects HSC activation and
differentiation in vitro (Aim 1) and in vivo (Aim 2). In addition, Aim 2 will examine the role of CCL5 on HSC
activation in a murine IBD model.

Public health relevance
Project Narrative In many inflammatory conditions such as inflammatory bowel disease platelet counts rise, resulting in thrombocytosis; what initiates this platelet up-regulation is not well understood but is a significant health concern, as platelets play an active role in exacerbating disease morbidity. My preliminary data identify a novel mediator of platelet formation, the protein CCL5, which targets the development and maturation of platelet precursor cells, megakaryocytes, and may play a role in mediating thrombocytosis in inflammatory bowel disease. A better understanding of this protein and the mechanisms by which it regulates megakaryocyte differentiation, maturation, and platelet formation may lead to novel therapies to help reduce disease burden in patients with inflammatory bowel disease and similar disorders, therefore reducing morbidity and mortality in the United States.